Reimagining HIV Prevention: Unveiling Opportunities to Strengthen Sexual Reproductive Health Services and Promote HIV Prevention among Cisgender Black Women at risk for HIV in Maryland

PROJECT SUMMARY
Cisgender Black women in the United States (US) shoulder a significant burden of HIV and sexually transmitted
infections (STIs), with persistent disparities driven by stigma, implicit bias, and structural barriers. The
disproportionate impact of HIV/STIs among Black women in the US underscores a stark race disparity that
requires urgent action to address social and structural determinants of health (SSDHs). Maryland, a priority state
for the Ending the HIV Epidemic (EHE) initiative, has struggled to mitigate these disparities despite significant
prevention efforts. HIV prevention efforts in the United States have often been siloed and focused on individual
behavior modification, leaving significant gaps in addressing the complex interplay between individual, structural,
and social determinants of health that contribute to the disproportionate burden of HIV and STIs among Black
women. This R36 dissertation proposal seeks to bridge this gap by conducting a convergent mixed-methods
study to gain a comprehensive understanding of how existing SRH services can be adapted or expanded to
better address the prevention needs of Black women at risk for HIV in Maryland. By examining the current
availability, accessibility, and acceptability of SRH services for this population, this study aims to identify gaps in
service provision and explore the personal experiences and perspectives of Black women who have accessed
or attempted to access SRH services. The findings from this research will inform the development of evidence-
based recommendations for adapting or expanding existing SRH services to integrate HIV testing and prevention
strategies into broader SRH services, for an improved prevention approach that appeals to vulnerable
populations and accounts for social, structural, interpersonal, and individual factors. This study aligns with EHE
efforts and the National Institute of Mental Health (NIMH) Division of AIDS Research (DAR) priorities, as it aims
to inform the development targeted interventions for Black women at risk for HIV in Maryland. By employing a
scientifically rigorous, theory-based approach, the findings will contribute to the development of interventions
that contribute to both proximal and long-term distal outcomes for HIV prevention.

Public health relevance
Project Narrative This dissertation proposal focuses on the unique needs of cisgender Black women in the United States, a vulnerable population facing disproportionately high rates of HIV and sexually transmitted infections (STIs). Current research is scarce on the complex interplay between sexual reproductive health (SRH) disparities and structural and social determinants of health among this population at risk for HIV in Maryland, particularly in understanding how to effectively integrate HIV prevention into existing SRH services despite these services being a primary and optimal mode for navigating the HIV prevention care continuum. Utilizing a mixed-method approach, this study investigates the availability, accessibility, and acceptability of SRH services, as well as personal experiences and perspectives, to inform the development of contextually appropriate and culturally sensitive HIV prevention strategies that address the root causes of these disparities.